Topologically complex DNA substrates to aid structure determination of the human topoisomerase IIa

Project Summary/Abstract
Type II topoisomerases (TOP2s) are essenƟal enzymes that maintain DNA topology using an ATP-dependent “strand-
passage” mechanism that physically moves one DNA segment through a transient, enzyme-mediated double-stranded
break in another. Under normal condiƟons, TOP2s perform strand passage to facilitate fundamental processes such as DNA
replicaƟon and transcripƟon; however, if improperly regulated, TOP2s also have the potenƟal to generate permanent DNA
breaks, a property that has been exploited by successful chemotherapeuƟc drugs that “poison” TOP2 to induce cytotoxic
DNA damage in cancer cells. MulƟple research approaches have helped characterize how TOP2 poisons bind the enzyme
and stabilize key reacƟon intermediates that accompany DNA break formaƟon. Despite these advances, structural studies
to date have only examined drug-bound TOP2s in complex with single, short DNA duplexes, precluding an understanding
of how therapeuƟc agents interfere with the strand passage reacƟon on physiologically relevant DNA substrates such as
chromaƟn and supercoils. Moreover, only one poison – etoposide – has been studied structurally in a naƟve context; all
other drugs were imaged with TOP2 aŌer soaking into crystals pre-formed with etoposide, raising concerns that the binding
mechanisms observed for these agents are arƟfactual and might diﬀer substanƟally from what has been reported thus far.
The objecƟve of the present applicaƟon is to capture currently elusive structural features of the TOP2 strand passage
reacƟon on more naƟve-like substrates in the presence of diﬀerent families of clinically used anƟ-TOP2 chemotherapeuƟcs.
Human topoisomerase IIα (TOP2A), which is used by cells to support chromosome segregaƟon and cell proliferaƟon, will
be used as a representaƟve model system. Strategies outlined in Aim 1 will employ chromaƟnized DNA substrates to beƩer
understand how a large, disordered C-terminal domain (CTD) present in TOP2A helps to recruit the enzyme to mitoƟc
chromaƟn, as well as how TOP2A may engage with the DNA entering and exiƟng a nucleosome. Binding assays using
truncated TOP2A mutants and CTD pepƟdes will idenƟfy elements that are responsible for TOP2A’s interacƟon with
nucleosomes, which will be imaged by cryo-EM. Aim 2 will use supercoiled minicircle DNAs and clinically deployed anƟ-
TOP2 drugs for Ɵme-resolved cryo-EM studies to capture TOP2A as it is undergoing strand passage. This approach will not
only enable a detailed structural analysis of elusive strand-passage intermediates, but also help resolve how diverse classes
of TOP2 chemotherapeuƟcs poison the strand passage reacƟon to form toxic, double-stranded DNA breaks. Together, the
proposed aims have the potenƟal to oﬀer new mechanisƟc insights into the TOP2 strand passage reacƟon that will not
only advance our understanding of how TOP2s safeguard genomic stability but will also unveil new possibiliƟes for
exploiƟng the reacƟon for therapeuƟc beneﬁt.

Public health relevance
Project Narrative Dysregulation of the DNA topoisomerase II (TOP2) catalytic cycle can lead to genome instability and cytotoxicity that are both exploited by and byproducts of certain anti-cancer drugs. A deeper understanding of how TOP2s physically pass DNA segments through one another depends on structural and biophysical studies in the presence of native-like, topologically complex DNA substrates such as chromatinized or supercoiled DNA. The proposed research will not only advance our understanding of TOP2 mechanism and biology, but also better establish how different classes of drugs bind to TOP2A in an unbiased manner, thereby advancing efforts to better target TOP2 for therapeutic intervention.